Admin Core

PROJECT SUMMARY/ABSTRACT
CANCER CENTER ADMINISTRATION
The overarching goal of the Winship Cancer Institute of Emory University administrative team (Winship
Administration) is to develop and implement strategic priorities to achieve Winship's mission to discover cures
for cancer and inspire hope for all. Winship Administration provides leadership and cost-effective administrative
services to further the conduct of transdisciplinary cancer research that addresses the needs of the Georgia
catchment area and beyond. Winship Administration is comprised of a team of administrative professionals that
operationalize the vision of Executive Director Suresh Ramalingam, MD. Under direction of Ramalingam and
the senior leadership team, Winship's Chief Administrative Officer and Associate Director for Administration
oversees the administrative team comprised of highly experienced senior operational directors with more than
75 total years of experience. The team is organized to efficiently provide administrative services with clear
responsibilities for information technology, finance, clinical trials, human resources, facilities, shared resources,
communications, research development, and CCSG management. Winship Administration facilitates the
strategic advancement of collaborative cancer-related research in a matrix organization, providing infrastructure
to promote the cancer research activities of its 179 members, with a particular focus on facilitating
transdisciplinary and translational cancer research with relevance to the catchment area. The administrative
team assists the Executive Director, senior leadership, program leaders and co-leaders, shared resource
directors, and members in fulfilling the mission of Winship by offering highly effective administrative
management, program planning, fiscal management, centralized services, and communications with
membership. The administrative unit coordinates the planning and evaluation activities, and supports faculty and
staff involved with the CCSG and its related activities, occupants of more than 843,616 gsf of Winship allocated
space, recipients of Winship pilot grants and philanthropic funds, participants in cancer disease site working
groups and programs, and participants in clinical oncology investigations. Winship Administration oversees the
largest clinical research operation at Emory and a cancer research enterprise that benefits patients in Georgia
by supporting the overall mission of the center.